New Therapeutic Approaches for Stratified High-REST GBM Subtype

Summary [Print using "Actual size" (Acrobat) or "Scale: 100%" (Preview)] for proper font size (11)]
Glioblastoma (GBM), a lethal human brain tumor, is made up of multiple molecular subtypes, suggesting that
therapy could be targeted to particular subtypes. Yet all newly diagnosed GBM patients are treated with a
similar therapeutic regimen, which results in overall poor patient outcomes. GBM tumors contain stem-like cells
(GSCs) that contribute to tumor initiation, growth, and resistance to standard-of-care temozolomide (TMZ) and
ionizing radiation (IR). Thus, GSCs present an excellent system in which to study the biology of GBM and
develop and evaluate targeted therapeutic approaches to GBM. Our long-term goal is to develop mechanism-
based therapeutic approaches to significantly advance the care of GBM patients. Our laboratory discovered
the transcriptional repressor REST as a stem cell promoter, and thus a critical oncogenic regulator, in
medulloblastoma. We and others discovered that REST also regulates oncogenesis in GBM and that tumors
with GSCs expressing high levels of REST (HR-GSCs) are molecularly and biologically distinct from tumors
with GSCs expressing low levels of REST (LR-GSCs). Further, GBM patients with an HR tumor transcriptome
signature have shorter survival than patients with an LR tumor signature, similar to our results with HR-GSC
versus LR-GSC tumors in mouse models. These studies have suggested that REST is a potential therapeutic
target in HR-GBM tumors. Yet there is no REST-specific therapeutic approach for stratified HR-GSC tumors.
The goal of this project is to determine therapeutic approaches for HR-GSC tumors using mouse intracranial
tumor models. First, information obtained here will determine whether targeting HR-GBM tumors with REST-
specific inhibitor, REST-VP16, is a valuable therapeutic approach for HR-GBM. Second, Information obtained
here will determine whether targeting HR-GBM tumors with REST downstream miR targets via exosome-
mediated delivery would promote therapeutic approaches for HR-GBM. Third, we will determine the underlying
regulatory network changes and transcriptome signatures in selected tumors with and without treatment
conditions. Such regulatory networks will provide information about changes in treatment-dependent
downstream pathways and targets. The transcriptome signatures could be useful to measure treatment
progression in a clinical setting. Fourth, we will determine the homing mechanism of Exosome-mediated
delivery of miRs to HR-tumors. Information obtained here will aid in designing exosomes with enhanced
homing capabilities to HR-GBM. Thus, the project has the potential to produce a novel, mechanism-based
therapeutic approach for the HR-GBM subtype, for which such approaches are limited.

Public health relevance
Narrative Glioblastoma is a highly heterogeneous and lethal human brain tumor that contains stem-like cells (GSCs) that contribute to tumor initiation, development, growth and resistance to conventional therapies. If successful, the proposed project would provide information on a new REST-miR-124-miR-203 mechanism-based therapeutic approach for stratified High REST-GSC tumor subtype in combination with standard-of-care temozoomide and ionizing radiation. It would also reveal treatment-dependent transcriptome signatures, providing mechanistic information about affected downstream targets and pathways.